Hepatic kisspeptin receptor signaling in nonalcoholic fatty liver

PROJECT SUMMARY
The increasing prevalence of obesity in the U.S.A. is associated with metabolic comorbidities
such as type 2 diabetes (T2D) and non-alcoholic fatty liver disease (NAFLD), a disease
characterized by excess liver fat accumulation in people who drink little to no alcohol. Although
there are many medications approved for T2D, no medications are approved for NAFLD, which
is now the leading cause of chronic liver disease and fastest-growing reason for liver
transplantation. The first stage of NAFLD is steatosis (fatty liver), that can progress to non-
alcoholic steatohepatitis (NASH) where fat accumulation in the liver is associated with
inflammation and scarring. As the liver cells are gradually replaced by scar tissue, the liver stops
functioning properly. The liver produces a peptide known as kisspeptin (KP) that circulates in the
blood. KP binds a protein known as the kisspeptin 1 receptor (KISS1R). Although KISS1R is
expressed in the liver, its function is unknown. Our new pilot data has revealed that KP/KISS1R
signaling can inhibit fat accumulation in the liver. Using genetically modified mouse models and
plasma derived from NAFLD patients, the proposed work will determine whether KISS1R
signaling prevents the development of NAFLD and the underlying mechanisms. In Aim 1, we will
investigate the mechanisms by which hepatic KISS1R signaling inhibits lipogenesis. In Aim 2, we
will determine the effect of increasing KISS1R signaling on the development of NASH and fibrosis.
Collectively, these clinically translational findings may identify KISS1R as a novel target for the
preventive treatment against the development of NAFLD.

Public health relevance
PROJECT NARRATIVE Non-Alcoholic Fatty Liver Disease (NAFLD) is the most common chronic liver disease, with prevalence growing in parallel with the obesity epidemic. NAFLD has no approved pharmacotherapy, due to incomplete understanding of its molecular mediators and compounded by its unpredictable progression to steatohepatitis (NASH) and fibrosis, major determinants of morbidity and mortality of this disease. This translational project focuses on a key factor secreted by the liver called kisspeptin, which we found controls fat accumulation in the liver and the development of NAFLD.